PHASE III STUDY OF EFFICACY OF DOSE LEVELS OF SANDOSTATIN LAR5

Primary objective of this study is to determine the efficacy of 10, 20 and 30mg doses of Sandostatin LAR compared to subcutaneous Sandostatin in providing continuous symptomatic control of malignant carcinoid syndrome when given at levels of four weeks.